Fully-Analog Motion Artifact Elimination Circuit for Compact and Low Power A-ECG Monitoring Devices

PROJECT SUMMARY
Motion artifact elimination is a key element for ambulatory ECG monitoring devices, since ECG
waveforms should be continuously recorded for a long period of time while the patient is performing
real-life activities such as working, exercising, or even sleeping. However, existing ECG motion
artifact elimination schemes require intensive computations, complicated circuitry, and high power
consumption, thus are not suitable for continuous long-term monitoring devices. Moreover, in order
to comply with the trends for wearable bio-medical sensors, the ECG motion artifact elimination
techniques should lead to a device with small form factor, low power consumption, and low cost.
The rationale of this research is that eliminating the motion artifacts by processing the corrupted
ECG signal in the analog domain within the ECG sensor frontend will have significant merit over
existing ECG motion artifact elimination techniques that are mostly realized with software algorithms
or digital processing. Our hypotheses will be verified through the following specific aims: 1) fully-
analog ECG motion artifact elimination technique development; and 2) validation of the
proposed fully-analog ECG motion artifact elimination technique.
We believe the outcomes of this work will contribute in early detection and prevention of heart failure
and stroke caused by cardiac arrhythmias and atrial fibrillation, which are currently affecting a
significant portion of the U.S. population. Furthermore, this work can also improve the quality of
remote ECG monitoring devices that are currently expecting an increasing demand due to the social
distancing requirements to prevent the spread of COVID-19.

Public health relevance
PROJECT NARRATIVE The goal of this research is to develop an ECG motion artifact elimination technique that can make ambulatory ECG monitoring devices (including the Holter and event monitors) compact, low power, and low cost, thus suitable for long-term remote monitoring. The outcomes of this work will contribute in public health by enabling early detection and prevention of heart failure and stroke due to cardiac arrhythmias and atrial fibrillation, which are currently the leading causes of death in the United States.